Optimizing Reactome TRUST

Project Summary/Abstract
We seek supplemental support to the core operating funding for the Reactome
Knowledgebase of human biological pathways and processes. Reactome is a curated
knowledgebase available online as an open access resource that can be freely used and
redistributed by all members of the biological and biomedical research communities. It is used
by clinicians, genomics researchers, and molecular biologists to interpret the results of high-
throughput experimental studies, by bioinformaticians seeking to develop novel algorithms for
mining knowledge from genomic studies, and by systems biologists building predictive models
of normal and disease variant pathways. Our curators, Ph.D.-level scientists, work closely with
independent investigators within the community to assemble machine-readable descriptions of
human biological pathways. Each pathway is checked and peer-reviewed prior to publication to
ensure its factual accuracy and compliance with the data model. A system of evidence tracking
ensures that the primary literature supports all assertions. Reactome uses community-standard
controlled vocabularies and ontologies to increase interoperability across resources. Pathways
are reviewed and updated regularly. Reactome pathways are available on our website for
browsing, downloading, and are accessible to in-house and third-party analysis tools. The
project is highly cited in the literature, has been used repeatedly to make significant biological
and clinical discoveries, and is incorporated into many high-impact informatics tools and
resources.
Over the next twelve months, to strengthen our adoption of the TRUST principles, we will
improve relevant features of our curation and quality assurance and develop an intelligent user
profiling system to better understand our user community and tool and data integrators. We will
build tools to monitor data usage to inform our update schedule and to improve user access to
legacy data. In parallel, we will [automate data collection, making our measures more detailed,
reliable, and consistent. To further demonstrate to the research community that Reactome is a
trustworthy data repository, and to drive our own development of further metrics we will apply
for CoreTrustSeal certification.

Public health relevance
Project Narrative Reactome is the largest open-access curated biological pathway database. Its authoritative and detailed content and accessible web site have directly and indirectly supported basic and translational research studies, enabling scientists, clinicians, researchers, students, and educators to find, organize, and utilize biological information to support data visualization, integration and analysis. We will devise additional metrics of curation consistency, quality, and completeness / currency, develop a detailed quantitative user profile and extend and revise our well-established authorship and curation standards to better support FAIR and TRUST principles, initiated by an application for CoreTrustSeal certification.